Upstate New York Immunology Conference

SUMMARY
To provide a forum for immunologists (investigators and trainees) from the Upstate New York area and
surrounding regions to present and discuss their research and build collaborations, the Upstate New York
Immunology Conference was initiated in 1998 and initially included 53 participants from three institutions. This
annual meeting has now grown to include ten institutions with an attendance of approximately 100 participants
annually. The specific objectives of the meeting are: 1) to provide a forum for members of the regional
immunology community to present their work, exchange ideas, and develop collaborations; 2) to give students
and postdoctoral fellows an opportunity to meet distinguished national leaders in the field and other trainees and
PIs from area institutions. 3) to allow students and postdoctoral fellows to present their work in a meeting format
and obtain appropriate project feedback; 4) to increase local, national, and international awareness of
immunology research being conducted in the region. The meeting also addresses career issues through
workshops organized by the keynote speakers. The next meeting will be held October 21-24, 2024, at The
Otesaga Resort Hotel, Cooperstown, NY. There will be two keynote speakers, four scientific symposia, two
trainee poster sessions, and four oral poster presentation sessions. All those wishing to attend will be
accommodated within The Otesaga Resort Hotel’s 300 rooms and extensive conference facilities.

Public health relevance
PROJECT NARRATIVE The annual Upstate New York Immunology Conference is now in its 26th year. It provides a forum for immunologists (faculty and trainees) from Upstate New York and surrounding regions to present and discuss their research and build collaborations.